Repurposing Gram-positive Antibiotics for Gram-Negative Bacteria using Antibiotic Adjuvants

Multi-drug resistant (MDR) Acinetobacter baumannii infections present an enormous ongoing challenge to public
health. Due to the frequent occurrence of multidrug resistance, current treatment options for A. baumannii
infections are limited. ß-Lactam antibiotics, especially carbapenems, represent the treatment of choice for
susceptible infections. However, carbapenem resistance is increasingly common, and for such infections there
is no consensus on the optimal alternative treatment. Because resistance has hitherto been relatively
uncommon, colistin has become a favored treatment in spite of the fact that deleterious side effects are common.
However, resistance to colistin in A. baumannii is becoming more frequent with the recent dissemination of
plasmid-borne colistin resistance genes (mcr-1-10) into healthcare facilities. Unfortunately, the recent track
record of discovery of new antibiotics that are active against Gram-negative bacteria is exceedingly poor, which,
coupled with the exit of Big Pharma from antibiotic discovery, has made the development of new therapies and
non-traditional therapeutic approaches vital. To combat this growing threat, we initiated a research program to
identify small molecules, termed antibiotic adjuvants, that potentiate the activity of macrolides against MDR A.
baumannii. To this end, we have successfully identified molecules that lower the minimum inhibitory
concentration (MIC) of clarithromycin up to 512-fold against all members of a panel of primary clinical A.
baumannii isolates from the Walter Reed Army Institute of Research (WRAIR) that encompasses nearly all
clinically relevant A. baumannii clades. Adjuvants also potentiate the activity of vancomycin up to 256-fold. Both
macrolides and vancomycin are typically viewed as “Gram-positive” selective antibiotics due to their inability to
cross the outer membrane of Gram-negative bacteria, Mechanistic studies have led to a working hypothesis that
these compounds overcome this barrier by increasing permeability of the outer membrane through inhibiting
lipooligosaccharide (LOS) production. Combinations of adjuvant with clarithromycin are effective in a Galleria
mellonella model of infection, which has been shown to predict outcome in murine models of infection in the
context of MDR A. baumannii. Therefore, combinations of such adjuvants with either clarithromycin or
vancomycin may form the basis for an efficacious approach to treating MDR A. baumannii infections for which
there are no effective antibiotics.

Public health relevance
The emergence of resistance to multiple antimicrobial agents by pathogenic bacteria has become a significant global public health threat. The Gram-negative bacterium Acinetobacter baumannii has evolved in the last 40 years from being a low-virulence pathogen of modest significance to become a leading cause of antibiotic- resistant infections worldwide, causing life-threatening infections of multiple tissues. The bacterium is a scourge of intensive care units and is responsible for about a million infections per year globally. Clinical outcomes are poor, with mortality rates as high as 70% reported. Therefore, multi-drug resistant A. baumannii infections present an enormous ongoing challenge and the development of novel approaches to treat these pathogens is an area of acute medical need.